Dendritic cell therapy for GvHD

Abstract.
Hematologic malignancies are often treated with allogeneic hematopoietic stem cell
transplantation (HSCT). However, HSCT is complicated by graft-vs-host disease (GvHD), a
severe, potentially lethal complication initiated when donor alloreactive T cells attack host cells
and organs. Despite the administration of prophylactic regimens for aGVHD as standard pre-
transplantation therapy, up to 60% of these patients develop aGVHD of grade II or higher, and
require additional immunosuppressive intervention. Thus, there is an urgent need to improve
pre-transplantation therapies to prevent aGVHD. We identified a probiotic exopolysaccharide
(EPS) that induces tolerogenic dendritic cells (DCs) that inhibit T cell proliferation, and we
found that EPS-treated human DCs (EPS-DCs) both inhibited T cell proliferation in mixed
lymphocyte reactions, and significantly increased survival of humanized NSG-HLA-A2 mice
after transplantation with human peripheral blood mononuclear cells (hPBMC). The data
indicate that a cell-based therapy using EPS-DCs can mitigate aGvHD, and the goal of this Phase
I R41 grant is to determine the in vivo fate of EPS-DCs and optimize protection from GvHD by
these EPS-DCs; optimize treatment to maximize the graft vs leukemia response; and establish
DC and T cell biomarkers of EPS-mediated suppression of GvHD. These studies will provide a
novel cell-based therapy for preventing GvHD in patients receiving HSCT. This cell therapy will
be translatable to humans because large numbers of EPS-DCs can be generated and frozen in
bulk and used as “off the shelf” treatment, for all patients, independent of MHC types.

Public health relevance
Graft versus host disease (GvHD) is a frequent outcome of hematopoietic stem cell transplants used to treat hematologic diseases, such as leukemia. Even after prophylactic drug treatment, up to 60% of these transplant patients suffer from GvHD. We have identified a means of reducing GvHD by administering cells pre-treated with a purified bacterial molecule, exopolysaccharide (EPS). EPS is non-toxic and the goal of this grant is develop EPS-DCs as a therapeutic agent to attenuate GvHD in humans.